Development of Conformer-Specific Anti-HLA Class II mAbs

Summary:
Murine MHC class II molecules exist in two distinct conformational states formed by differential pairing of
class II transmembrane (TM) domain GxxxG dimerization motifs (i.e., M1 and M2 paired class II), and these
two conformers are linked to different immunological functions. Moreover, we have recently reported that: 1)
HLA class II HLA-DR, DP and DQ molecules mirror mouse class II in possessing three TM domain GxxxG
motifs, 2) in silico molecular modeling reveals that HLA-DR and DQ TM domains can adopt energetically
favorable M1 and M2 paired states, and 3) hybrid class II molecules with an HLA-DR or DQ TM domain can
adopt both an M1 and M2 conformation. In this proposal, we show that a commercially-available anti-HLA
class II mAb (H0002) exhibits differential reactivity to wild type vs. an HLA-DR M1 GxxxG>VxxxV mutant
molecule (which would have an altered conformer state). These findings strongly suggesting that like mouse
class II, human class II molecules also exist in two distinct conformational states (M1 and M2 paired class II).
In addition to published work on the differential signaling of M1 vs. M2 paired class II in normal B murine
cells, our preliminary studies show that M1 and M2 class II are linked to distinct signaling pathways in
neoplastic B cells. Herein, we show that while selective engagement of M1 class II inhibits B cell lymphoma
proliferation, co-ligation of M1 and M2 class II blocks this effect. This is important because three anti-HLA-DR
mAbs (IMMU-114, 1D09C3 and Hu1D10) have undergone clinical trials as treatment for B cell
leukemia/lymphoma with mixed results. Since the conformer specificity of these three anti-DR mAbs is
unclear, it raises the possibility that anti-DR mAb therapeutic efficacy is linked to mAb conformer reactivity.
These findings lead to the hypothesis that like mouse class II, human HLA class II molecules exist in two
distinct conformational states based on alternative pairing of transmembrane domain GxxxG dimerization
motifs and that these two distinct HLA class II conformers are linked to different clinically-relevant B cell
signaling pathways. To test this core hypothesis, we will; 1) Define the HLA-DR conformer specificity of a large
panel of available anti-HLA class II mAbs, including those that have undergone clinical trials as therapeutics for
B cell leukemia/lymphoma, and 2) Develop a panel of new monoclonal antibodies that recognize the
conformational differences between M1 and M2 paired human HLA-DR and HLA-DQ class II molecules.
Completion of these aims will help bring the M1/M2 class II conformer paradigm to the HLA field, provide
insight into whether there is a correlation between the conformer-specificity of clinically-relevant anti-DR mAbs
and demonstrated therapeutic effect, and provide the field with a new set of tools (i.e., conformer-specific anti-
HLA-DR and anti-HLA-DQ mAbs) to further investigate the role of M1 and M2 HLA class II in human health
and disease.

Public health relevance
Narrative: Human HLA class II molecules are expressed on B cells, dendritic cells and macrophages, mediate important immune cell interactions and adopt two different shapes or conformations. In addition, monoclonal antibodies against HLA class II molecules can be used therapeutically to treat diseases such as B cell leukemia or lymphoma. The goal of this project is to define the conformer-reactivity of existing and newly developed HLA anti-class II monoclonal antibodies to provide the tools for the analysis of HLA class II conformation and immune function. 1